Development of a digital acoustofluidic system for automating liquid handling in biomedical research

PROJECT SUMMARY
This R01 application is responsive to the NIH initiative PAR-19-253 “Focused Technology Research and
Development”. Automated liquid handling technologies are valuable in many areas of biomedical research. For
example, robotic pipetting systems have been extensively utilized to automate assays, thereby eliminating errors
associated with manual pipetting and significantly improving reproducibility. However, the majority of automated
liquid handling technologies suffer from a fundamental constraint: they rely on physical contact with a solid
structure in order to manipulate liquid reagents. Therefore, traces of a reagent inevitably adsorb onto the contact
surface and can possibly later dissolve into another liquid sample. Thus, the risk of cross-contamination due to
this undesirable “fouling of the surface” limits the transport surfaces to a single type of working liquid plus reagent
combination. Recently, we invented digital acoustofluidics (DAF), an acoustic-based, programmable, contact-
free, liquid handling technology, which overcomes the key obstacles associated with the existing liquid handling
methods. In this R01 project, we will develop and validate a DAF fluid processing system with the following
features: (1) Rewritability, programmability, and ability to perform complex, cascade reactions: We will
demonstrate the ability of DAF to transport and mix ‘fluidic bits’ (i.e., droplets) along prescribed, arbitrary routes
without cross-contamination, leading to a 104-fold increase in the number of allowable combinations of reagent
inputs on a single device (as compared with conventional platforms); (2) Biocompatibility: Instead of being
directly subjected to strong acoustic pressure or high electric fields, the droplets are manipulated in a
contactless, gentle manner. Our preliminary results show that the DAF platform has no significant effect on the
viability of cells; (3) Versatility: DAF is not restricted to fluids with specific acoustic, electrical, hydrodynamic, or
magnetic properties. This versatility makes DAF suitable for handling a wide range of liquids, even for challenging
samples such as low-polarity fluids (e.g., organic solvents), sticky or viscous samples (e.g., blood and sputum),
and solids (e.g., fecal samples and model organisms); (4) Miniaturization and convenient integration: Our
DAF platform provides an unprecedented level of miniaturization and cost-effectiveness compared with existing
robotic liquid handling systems. In addition, it is designed to be integrated with a variety of multi-well plates,
enabling it to be seamlessly integrated into existing biomedical research laboratories. With the aforementioned
advantages, the proposed DAF technology has the potential to exceed current industry standards, address
unmet needs in the field, and provide a compelling platform for the development of a robust, rewritable, high-
throughput, and digitally-programmable fluidic processor. We will validate its performance across two established
biomedical applications: protein crystal chemistry, and high-throughput drug screening. In this regard, we aim to
demonstrate the far-reaching potential of DAF to enable improved research in areas ranging from clinical
chemistry to fundamental biology.

Public health relevance
Project Narrative Automated liquid handling systems have transformed biomedical research laboratories by enabling scientists to conduct programmable reactions from low-volume samples. However, most existing systems suffer from drawbacks such as surface adsorption, cross contamination, and limited programmability. The objective of the proposed project is to develop an acoustic-based technology that overcomes these key obstacles and enables a highly programmable, biocompatible, and high-throughput fluidic processor.